A novel role for a bicistronic calcium channel gene in neurodevelopment and neurodegeneration

Spinocerebellar ataxia type 6 (SCA6) is an untreatable neurodegenerative disease due to CAG repeat expansions in the gene, CACNA1A, that cause causing degeneration of cerebellar Purkinje cells and ataxia. There is no known treatment, although gene-silencing approaches targeted towards silencing the toxic protein have shown promise in other CAG repeat disorders. The CACNA1A mRNA encodes two proteins, the α1A subunit of the neuronal P/Q-type voltage-gated Ca2+ channel, and α1ACT, a protein discovered by my group, that also bears the polyQ tract. This is critical, since homozygous CACNA1A deletion is lethal, suggesting that complete gene silencing approach to treatment will be harmful. However, studies using both mouse genetic models and human-derived neuronal cells have convincingly excluded a role of the expanded polyQ tracts in altering P/Q channel function in SCA6. Furthermore, our recent evidence suggests that SCA6 is mediated by the second CACNA1A gene product, α1ACT, a transcription factor (TF) critical for cerebellar cortical development, dispensable in mice in adulthood. α1ACT with expanded polyQ tract (α1ACTSCA6) impairs its molecular function and is toxic in Purkinje cells (PCs). There are two goals to this project: 1. To determine whether expanded α1ACT causes SCA6 by a disruption of its TF function or by a direct toxic effect. 2. Prove that selective silencing of α1ACT, the second CACNA1A gene product, is an effective treatment for SCA6. α1ACT is expressed by a novel mechanism via an internal ribosomal entry site (IRES) within CACNA1A, molecular treatments, targeted to the IRES to block α1ACT translation and can prevent disease in an acute SCA6 model. The long range goal of this project is develop a treatment for SCA6. To address this, as defined in the Aims below, we will identify the key protein domains and post-translational modifications that determine the physiological and pathological properties of α1ACT and determine the effects of α1ACTWT and α1ACTSCA6 on chromatin accessibility and dsDNA breaks. We will demonstrate that IRES-directed therapies are an effective treatment for SCA6. Aim 1. Define the key protein domains and post-translational modifications that determine the transcription factor properties of α1ACT and its toxicity in SCA6. Aim 2. Determine the effects of α1ACTWT and α1ACTSCA6 on chromatin accessibility and dsDNA Aim 3. Prove that IRES-directed therapies correct the molecular, cellular and clinicopathological features of SCA6.

Public health relevance
Gene silencing therapies have shown great promise in the treatment of neurodegenerative disease. To be effective the function of the gene product being silenced and the long term consequences of this silencing need to be fully understood. In this study will analyze the structure function, and mechanism action of the newly identified protein, α1ACT. Subsequently we will inhibit its expression using a novel gene silencing approach and demonstrate that the toxic features of SCA6 are abolished.